Development of an Educational Video in Support of Vet-LIRN Antimicrobial Stewardship Efforts

Antimicrobial drugs are critical to the practice of medicine whether the patients are humans or animals. Annually, these drugs save millions of lives, but the rapid rise of antimicrobial resistance threatens their utility. In veterinary medicine, there has been a recent focus to improve and refine the use of these critical drugs through the development antimicrobial stewardship efforts. Previous work from our group supported by the Veterinary Laboratory Investigation and Response (Vet-LIRN) has led to the development of three educational tools (standardized cases, validated rubrics and a metacognitive mnemonic framework) designed to improve students’ abilities to select appropriate antimicrobial agents. The aim of this project is to create two educational videos for wider distribution of these antibiotic stewardship tools. We will utilize an expert video production group at the University of Pennsylvania to develop these videos using their standard process. The videos will be important for the dissemination to and accurate implementation of these tools into veterinary curricula. When complete, the videos will be made available through Vet-LIRN and through the University of Pennsylvania’s Veterinary School Website.

Public health relevance
In order to mitigate the spread of antimicrobial resistant bacteria, there is a need to improve and increase antimicrobial stewardship education in veterinary settings. This project is to develop two videos to promote standardized educational cases, validated rubrics and a metacognitive mnemonic framework designed to teach veterinary students antimicrobial stewardship.